Role of extracellular matrix remodeling on high-grade serous ovarian carcinoma immune evasion

The broad goal of the proposed work is to understand how the hypoxia-induced extracellular matrix (ECM)
remodeling in ovarian cancer affects immune evasion. Understanding this concept would have a broad impact
on identifying effective immunotherapies for ovarian cancer, a particularly deadly form of cancer in women. The
ECM not only provides structural and biochemical support to tumor tissue, but also the ECM undergoes
remodeling which alters the composition and mechanical properties of the tumor microenvironment, directly
influencing immune evasion mechanisms. With this in mind, it has been established that hypoxia can influence
tumor immunosuppression and this inadequate tissue oxygen, or hypoxia, promotes ECM remodeling. However,
little is known about the role of the hypoxia-induced ECM in immune evasion and response to immunotherapy
in ovarian cancer.
Unfortunately, there is a scarcity of preclinical models providing recapitulation of the hypoxia-induced ECM
remodeling of ovarian tumors. Thus, new technologies that allow the study of the hypoxia-induced ECM
remodeling and its impact on immune evasion are crucially required. In studies leading to this application, we
developed a patient-derived 3D tissue culture system capable of recapitulating the hypoxia-induced ECM and
tumor-immune interactions. Specifically, we will utilize engineering approaches and patient-derived samples in
order to assess the effect of the hypoxia-induced ECM remodeling on the tumor-immune cycle and further
validate new treatments to overcome immune evasion. Successful completion of the proposed work will allow
us to investigate the role of the hypoxia-induced ECM remodeling on cancer immune evasion, to identify how
tumors escape immune surveillance, and to ascertain novel strategies to re-sensitize cancer cells to immune
cells reducing tumor immune evasion in a precision-based manner.

Public health relevance
One of the major components of the tumor microenvironment is the extracellular matrix (ECM), which undergoes remodeling and contributes to immune evasion mechanisms. Low oxygen is a key regulator of ECM remodeling, however, little is known about the role of the hypoxia-induced ECM remodeling in immune evasion and response to immunotherapy. We will use patient-derived 3D model quantitative research methods to gain insight into the recreation of the hypoxia-induced ECM remodeling and its role in immune evasion.